COMMUNITY CLINICAL ONCOLOGY PROGRAM

This application is from an eleven hospital consortium in Southwest Washington and Oregon. Formerly known as the Southwest Washington Community Clinical Oncology Program, now proposing to rename the consortium the Northwest CCOP to reflect a change in geographical representation. This program will continue its efforts to increase the number of patients entered on NCI approved Treatment and Cancer Control Protocols and continue the firm linkages established between the community and three Research Bases (the Southwest Oncology Group, the Fred Hutchinson Cancer Research Center and the Radiation Therapy Oncology Group). In addition, this CCOP will continue to: 1) provide a basis for involving a wider segment of the community in continuing Cancer Control Research and investigate the impacts in the community and, 2) to increase involvement of primary health care providers with CCOP investigations by facilitating wider community participation, and 3) improve care of non-protocol patients. The original program was formed in 1981 with 150 primary care physicians cooperating in the effort. Building on this base in Southwest Washington, and with the addition of Kaiser Permanente of Portland, Oregon, a tight-knit core group of Radiation and Medical Oncologists with interests in Clinical Research and Cancer Control has developed. They have formed a cohesive, controlled, high quality Research Plan enrolling over 270 patients on NCI approved Clinical Treatment Protocols and 457 patients on NCI sponsored Cancer Control programs. This group plans to continue and improve existing research efforts with the intent of entering 202 patients (194.7 credits) on Clinical Trials and 391 patients (246.5 credits) in approved Cancer Control activities. During this funding period, the Principle Investigator has entered over sixty patients on the Thymosin Study at FHRC and NCI.